Role of respiratory viral infections and inflammation in promoting metastatic outgrowth in the lung

The leading cause of breast cancer deaths is metastasis. Metastatic relapse can occur months to years
after the initial diagnosis and treatment of the primary tumor. Cancer cells can disseminate from the
primary tumor into different tissues including lungs and remain in a dormant state for years to decades.
Awakening of these dormant disseminated cancer cells (DCC) leads to metastasis. Finding factors that
trigger the awakening of dormant DCC and developing strategies to reduce the risk of awakening is
therefore an unmet need. While it is known that inflammation is a key contributing factor to the
awakening of dormant DCC, no studies have investigated whether inflammation triggered by viral
respiratory infections (a very common infection worldwide) in the lung can promote the expansion of
DCC and lead to the development of metastases. Our recent studies using a mouse model of breast
cancer DCC dormancy in the lung have revealed a dramatic increase in DCC awakening and expansion
in the lungs following influenza virus infection. Our data support the hypothesis that respiratory viral
infections can promote DCC awakening and expansion through two phases: first, through IL-6
dependent DCC awakening and expansion, and second, CD4 T-cell mediated protection from
elimination (in part by CD8 cells). We further show that infection with a mouse-adapted SARS-CoV-2
promotes a similar awakening and expansion of DCC in mice. Finally, epidemiological studies reveal
how prior infection with SARS-CoV-2 infection increases metastatic progression in lungs and cancer-
related deaths for cancer survivors. We propose to determine mechanisms by which acute respiratory
viral infections induce the awakening of dormant DCC leading to metastatic disease, whether and how
such infections can prime DCC for activation by subsequent exposures, and how CD4 and CD8 cells
differentially control the persistence of expanded DCC during influenza virus infection.
Impact: Proposed studies to understand how different pulmonary viral infections alter DCC dormancy
and host immune responses, to determine the consequences for progression to metastatic disease,
and to explore underlying mechanisms, should yield valuable and actionable insight into the key cell
types and molecular mediators, informing early detection and prevention strategies for at-risk
individuals.

Public health relevance
Given the known risk of lethal metastatic recurrence, years or decades after initial diagnosis, together with the prevalence of respiratory viral infections, the implications for the research proposed here are profound. By establishing clear links between common respiratory viral infections such as SARS-CoV-2 and the awakening and progression of metastatic dormant cancer cells in the lungs, these studies could lead to i. greater risk mitigation for cancer survivors during respiratory viral seasons, epidemics and pandemics, ii. enhanced early detection in cancer survivors who experience respiratory viral infections, iii. testing of interventions to be applied during or after respiratory viral infections to reduce subsequent risks for metastatic progression, and iv. development of post-infection biomarkers of metastatic recurrence risk. Mechanistic insight gained from the proposed studies will guide these efforts, by identifying the key cell types and their phenotypes that mediate both DCC awakening in response to viral infections and DCC elimination, and the key soluble factors and cell signaling/transcription pathways.